NEURODEVELOPMENTAL FOLLOW-UP AFTER EXERCISE IN PREGNANCY

The goal of this protocol is to perform a detailed assessment of the neurodevelopmental and morphometric outcome of the offspring of female runners, aerobic dancers and matched controls, and to correlate the findings with maternal exercise performance during pregnancy. These data will be used to test the hypothesis that the neurodevelopmental performance and morphometric outcome of the offspring of exercising women is inversely proportional to exercise performance.